NF-kappaB signaling in dystrophic cardiomyopathy

DESCRIPTION (provided by applicant): Duchenne muscular dystrophy (DMD) is a deadly childhood disease that affects both skeletal and cardiac muscles and for which there is no effective treatment or cure. The majority of patients with DMD and those with a milder form of the disease, Becker muscular dystrophy (BMD) develop progressive cardiomyopathy that eventually leads to death in 20 and 50% of patients, respectively. We propose a mechanism of dystrophic cardiomyopathy disease progression that is dependent on signaling through the transcription factor nuclear factor-kappaB (NF-κB). Our previous work has demonstrated the requirement for NF-κB signaling in dystrophic skeletal muscles, however the implications of NF-κB signaling in dystrophic cardiac muscle remain unknown. In the proposed studies, Aim 1 will evaluate the relevance of NF-κB in dystrophic cardiomyopathy. Dystrophin- deficient mice (mdx) will be used as a model to determine how early NF-κB becomes activated, the specific NF-κB signaling pathway involved (classical vs. alternative), and the identity of cell types expressing NF-κB in dystrophic hearts. EMSA analysis, NF-κB reporter mice, immunostaining, western blotting, kinase assays, and FACS analysis will be used to evaluate Aim 1. Aim 2 will determine the requirement for NF-κB signaling in disease development. Mdx mice deficient for NF-κB signaling in all cell types and specifically in cardiomyocytes will be evaluated for histological, functional, and gene expression differences compared to mdx mice without NF-κB ablation. Aim 3 will investigate the mechanism by which NF-κB promotes dystrophic cardiomyopathy. Real time RT-PCR will be performed on cardiomyopathy-related genes that are known targets of NF-κB. Genes will be placed in functional groups (eg: fibrotic, inflammatory, survival) to determine if NF-κB is mechanistically promoting cardiomyopathy by targeting a specific group of genes. Additionally, a genome- wide search for all NF-κB targets will be performed using ChIP-sequencing to ensure an unbiased approach for evaluating NF-κB signaling targets is undertaken. The completion of these aims will provide significant insight into the role of the NF-κB signaling pathway in cardiomyopathy, as well as the relevance for targeting this signaling modulator for the treatment of DMD and BMD.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH The overall goal of this project is to understand how the protein nuclear factor-kappaB (NF-κB) is contributing to heart disease in Duchenne and Becker muscular dystrophy. Understanding the role of NF-κB signaling in the heart is critical for determining if we can target this pathway for therapy to slow disease progression and improve quality of life for patients.